YRC PEPTIPEDIA

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The YRC database contains approximately 200 million spectra from mass spectrometry collaborations and technology development projects. A project has been initiated to disseminate all of these data to the public in the form of a multifaceted data resource, where the data may be downloaded or interrogated via a web interface, web services, or as a downloadable spectrum library.